Signaling importance of ‘functionless’ lyso-PAF, an inactive form of platelet activating factor, in melanoma with mutant Nras

Project Summary/Abstract
Although many human cancers share similar metabolic alterations, including the Warburg effect, it remains
unclear whether oncogene-specific metabolic alterations are required for tumor development. We identified
phospholipase A2G7 (PLA2G7) as a “synthetic lethal” partner of Nras Q61K/R mutants in melanoma cells, which
is selectively important for cell proliferation and tumor growth potential of melanoma cells expressing mutant
Nras, but not in cells expressing BRAF V600E. PLA2G7 (a.k.a. platelet-activating factor acetylhydrolase
(PAF-AH)) is a secreted enzyme produced by leukocytes including macrophages, T cells, and mast cells, which
catalyzes the degradation of phospholipid platelet activating factor (PAF) and production of a biologically inactive
phospholipid product Lyso-PAF, blocking PAF-induced inflammation and vascular permeability. Mechanistically,
we found a surprising intracellular signaling function of PLA2G7. Knockdown of PLA2G7 results in decreased
S338 phosphorylation of Raf-1 in cells, which is crucial for Raf-1 activation and consequently essential for mutant
Nras-dependent MAPK activation, but dispensable for MAPK activation by BRAF V600E, which bypasses Raf-1.
This explains the selective importance of PLA2G7 only in mutant Nras-expressing cells. Moreover, Lyso-PAF, a
biological inactive form of PAF that has been suggested to be “functionless”, may contribute to p21-activated
kinase 2 (PAK2)-dependent S338 phosphorylation of Raf-1, through direct binding to PAK2, likely in the catalytic
cleft, leading to enhanced PAK2 kinase activity by stabilizing ATP binding. Thus, we hypothesize that
“functionless” Lyso-PAF has an intracellular and signaling role that is selectively important for mutant Nras
transformation by contributing to PAK2-dependent S338 phosphorylation of Raf-1, and PLA2G7 represents an
alternative therapeutic target to selectively treat melanoma cells expressing mutant Nras. We have identified and
validated a compound Succimer as a selective and potent PLA2G7 inhibitor. Three specific aims are proposed:
(1) To determine the selective importance of the PLA2G7-Lyso-PAF axis in the proliferative and tumor growth
potential of melanoma cells expressing mutant Nras, which is “bypassed” in cells expressing BRAF V600E, using
diverse human melanoma cell lines and “isogenic” cell line pairs. (2) To explore the molecular and structural
mechanisms by which Lyso-PAF contributes to PAK2-Raf-1 axis through directly binding to PAK2 catalytic cleft
and consequently stabilizing ATP binding. (3) To evaluate PLA2G7 as an alternative target to selectively
attenuate proliferative and tumor growth potential of mutant Nras-expressing melanoma cells in vitro, and in
patient-derived xenograft (PDX) models of melanoma in vivo, respectively, using our newly identified PLA2G7
inhibitor, Succimer, and elucidate the underlying structural mechanism for further structure-activation
relationship (SAR) studies.

Public health relevance
Project Narrative Although many human cancers share similar metabolic alterations, including the Warburg effect, it remains unclear whether oncogene-specific metabolic alterations are required for tumor development. We found that phospholipase A2G7 (PLA2G7) is selectively important in Nras Q61K/R mutants in melanoma cells, which is a secreted enzyme that catalyzes the degradation of phospholipid platelet activating factor (PAF) and production of a biologically inactive phospholipid product Lyso-PAF to regulate PAF-induced inflammation. We hypothesize that “functionless” Lyso-PAF has an intracellular and signaling role that is selectively important for mutant Nras transformation by contributing to PAK2-dependent S338 phosphorylation of Raf-1, and thus PLA2G7 represents an alternative therapeutic target to selectively treat melanoma cells expressing mutant Nras.